Mechanism of the Usher in Assembly and Secretion of Pili

PROJECT SUMMARY
Pathogenic bacteria must assemble and secrete virulence factors to interact with host tissues and cause disease.
Gram-negative bacteria have an outer membrane (OM) in addition to a cytoplasmic membrane and must secrete
virulence factors across both these barriers. The mechanisms by which this occurs are not well understood.
This project uses the chaperone-usher (CU) pathway as a model system with which to probe mechanisms of
protein secretion and virulence factor biogenesis in Gram-negative bacteria. The CU pathway is a conserved
secretion system dedicated to the assembly of virulence-associated surface structures termed pili or fimbriae.
Pili are hair-like polymers that typically function as adhesive organelles and have roles in colonization of surfaces,
biofilm formation, interactions with host cells, and pathogenesis. The prototype structures assembled by the CU
pathway are the type 1 and P pili expressed by uropathogenic Escherichia coli. E. coli is the primary causative
agent of urinary tract infections, a major healthcare burden and source of antibiotic resistance. Type 1 and P pili
are critical virulence factors that mediate colonization of the bladder and kidneys, respectively. The CU pathway
requires two components for secretion across the OM: a periplasmic chaperone and an integral OM protein
termed the usher. The chaperone directs proper folding of pilus subunit proteins and maintains the proteins in
an assembly-competent state. The usher is a dynamic molecular machine that catalyzes the formation of
subunit-subunit interactions, promotes ordered polymerization of the pilus fiber, and provides the channel for
secretion of the pilus to the cell surface. Pili are critical for initiating and sustaining infection, and the CU pathway
represents an attractive target for the development of anti-virulence therapeutics, particularly for infection of the
urinary tract. The goals of this proposal are to probe the structure and function of the usher to gain a complete
understanding of the molecular mechanisms governing pilus biogenesis at the bacterial OM, and to exploit the
knowledge and expertise gained over the course of this project to develop small molecule inhibitors of the CU
pathway. This proposal will test the hypothesis that the usher distinguishes among and organizes pilus subunits
to guarantee the assembly of adhesive organelles, and that the usher and usher-chaperone-subunit interfaces
are targets for small molecule inhibition. The Specific Aims of this proposal are to: 1) Determine how the usher
is activated and initiates pilus biogenesis; 2) Define molecular details of the subunit incorporation and pilus
extension cycle; and 3) Identify small molecule inhibitors of usher function in pilus biogenesis. The proposed
studies will answer fundamental questions of protein secretion and the regulated assembly of complex organelles
at the bacterial OM, and will provide a foundation for the development of novel therapeutic agents that selectively
disrupt virulence factor biogenesis.

Public health relevance
RELEVANCE The work described in this proposal will elucidate fundamental mechanisms of protein translocation across membranes, the assembly of complex organelles, and virulence factor biogenesis at the bacterial outer membrane. The emergence of multidrug resistant bacteria represents a major health threat, for which new alternatives to traditional antibiotics are urgently needed. This proposal will identify novel anti-virulence compounds that inhibit assembly of adhesive pili by Gram-negative bacterial pathogens, selectively disrupting host-pathogen interactions required to initiate and sustain infection.